Functional Connectivity and Baseline Networks of the White Matter Brain: Development and Dissemination of Algorithms and Tools

PROJECT ABSTRACT
The discovery of functional brain connectivity (FC) and functional networks (FNs) have propelled the
neuroimaging field, particularly in functional magnetic resonance imaging (fMRI), which has experienced an
exponential growth in recent years. FNs have allowed us to better understand extrinsic and intrinsic brain
properties in various disease and healthy states, leading to better characterization of neuropsychiatric
disorders. However, current fMRI analyses are constrained to the gray matter (GM) region of the brain and
fMRI data from the white matter (WM) region are often discarded, which makes up approximately 50% of the
brain by volume. Many brain disorders have been associated with WM deficiencies, since WM is critical for the
transmission of information to the GM cortical areas. Despite findings of blood-oxygen-level-dependent
(BOLD) signals in the WM, WM-FNs are yet to be fully characterized, and neither the mechanism by which
WM-FNs may affect GM-FNs, nor how WM-FNs are associated with phenotypic traits are known.
The long-term goal of this project is to better understand the effect of WM-FNs on normal cognitive
functions of the human brain and apply fMRI data from various healthy and diseased populations for more
reliable diagnostics and monitoring. The rationale for this study is based on our preliminary studies which
investigated WM-FNs using the Human Connectome Project dataset. We found that WM-FNs are correlated
with subregions of the corpus callosum, a critical WM region relaying information between the two cortical
hemispheres. Furthermore, we determined an overlap between the WM-FNs and tracts from diffusion tensor
imaging (DTI). In this study we will examine WM-FNs of the whole brain using resting fMRI data from two large
independent cohorts. We hypothesize that the FN measures derived from WM will be similar to that of GM and
the metrics can be used to reliably predict phenotypic traits. The hypothesis will be tested with the following
specific aims: Aim1: To develop and evaluate the time-series, FC and FN characteristics of WM of the whole -
brain; Aim 2: To investigate WM-phenotype associations and the predictability of phenotypes using WM-FNs;
and Aim 3: To develop and disseminate a WM-FN toolbox. To the best of our knowledge, this study will be the
first to examine the reliability and validity of WM-FNs in resting fMRI data, and its relation to brain function. The
proposed work holds significant contribution since it will facilitate the use of WM-FN methods for the
neuroimaging community, which currently lacks the necessary analytic tools to reliably characterize WM
function. This study will provide a strong foundation f or future clinical use of both WM-FNs and GM-FNs, to
understand brain function more comprehensively, in addition to facilitating the use of reliable and reproducible
WM-FC methods.

Public health relevance
PROJECT NARRATIVE Functional connectivity and functional networks of the brain’s cortical gray matter have allowed us to better understand how different regions of the human brain are connected. In this project we will investigate functional networks of the brain’s white matter, a critical region of the brain that is often overlooked in functional magnetic resonance imaging studies. Findings from this study will help to understand the brain as an integrated system of both white matter and gray matter and help to better diagnose and treat neuropsychiatric disorders.